Integrating GPS, GIS, and Ecological Momentary Assessment to Determine the Effect of Home and Neighborhood Context on Adolescent Sleep

Project Summary/Abstract
Insufficient sleep doubles the risk of obesity among youth and increases the risk of cardiovascular disease
(CVD) in adulthood. Over 75% of US high school students do not meet national sleep recommendations. Given
these alarming trends, a better understanding of the environmental determinants of sleep in adolescents is
needed in order to identify targets for interventions and public health strategies to promote healthy sleep. While
research increasingly suggests that home and neighborhood context impact sleep, key methodological issues
limit understanding of the environmental determinants of adolescent sleep. Research on the influence of
neighborhood-level factors (e.g. crime, disorder) on sleep typically focuses on the area surrounding
adolescents' homes. This approach does not account for mobility and the accumulation of exposures across
multiple contexts (e.g. home, school, in transit) during daily activities, leading to exposure misclassification.
The home sleep environment (e.g. light, noise) may also vary by night, but is typically assessed at a single
timepoint. Mobile health methods including smartphone GPS tracking and ecological momentary assessment
(EMA) offer an innovative opportunity to overcome the limitations of past studies by developing person-
centered measures of environmental exposures that account for variation over space and time. With this
career development award, I will develop critical skills in environmental exposure assessment and health
behavior science necessary to pursue a novel independent research program that identifies modifiable
environmental determinants of sleep and other CVD-related outcomes and their mechanisms of effect using
advanced, cutting-edge methods. In the proposed research study, I will enroll a diverse cohort of 160
adolescents aged 15-18 through a large urban pediatric primary care research network. I will use smartphone
GPS tracking, EMA, geographic information systems (GIS), and actigraphy to collect high-resolution
longitudinal data on adolescents' exposures to the home and neighborhood context and sleep outcomes over a
14-day period. The research aims include 1) quantifying adolescents' exposure during daily activities to
neighborhood factors hypothesized to influence sleep, 2) determining the extent to which adolescents'
exposure to adverse sleep environments varies across nights and by housing conditions, and 3) determining
the extent to which daily measures of home and neighborhood exposures are associated with adolescent sleep
outcomes. With guidance from an expert, interdisciplinary mentorship team at the Children's Hospital of
Philadelphia and the University of Pennsylvania, I will obtain training in 1) space-time data collection and
analysis, 2) ecological momentary assessment, and 3) sleep research. Completion of the K01 research and
training plan will prepare me to compete successfully for R01-level research funding and will uniquely position
me as an independent investigator who conducts large-scale epidemiologic investigations on spatiotemporal,
environmental determinants of child and adolescent health behaviors related to cardiovascular health.

Public health relevance
Project Narrative Recommendations for addressing the high burden of insufficient sleep among adolescents largely focus on individual-level factors (e.g. sleep hygiene), but the contribution of adolescents' larger environmental context to sleep health has been understudied. The proposed study will expand traditional approaches to assessing environmental effects on health by using advanced, spatiotemporal exposure assessment methods to understand how adolescents' home and neighborhood environments adolescents influence their sleep. This work will provide foundational knowledge regarding adolescents' environmental risks that will lead to an improved understanding of the determinants of adolescent sleep and development of an approach that can be applied across a wide range of modifiable health behaviors to inform preventive interventions and health policies aimed at improving cardiovascular health across the lifespan.